CHARACTERIZATION OF DEVELOPMENTAL MUTATION CAUSED BY RETROVIRAL INSERTION

To identify and isolate developmental genes, we are carrying out insertional mutagenesis studies in transgenic mice derived from retrovirally infected embryonic stem (ES) cells. We have analyzed a strain segregating 23 proviruses (412 strain) to determine if any are associated with insertional mutations. We have genetic and molecular evidence that 3 of the proviruses cause recessive prenatal lethality. We have circumstantial evidence that at least one additional provirus is associated with an abnormal visible phenotype that is reminiscent of a previously defined mutation, disorganization (Ds). The molecular and phenotypic analysis of these potential insertional mutations is underway.